m6A RNA modification as a regulator of R-loop homeostasis and gene expression in aging and neurodegeneration

The N6-methyladenosine (m6A) is the most prevalent, reversible modification of RNA in eukaryotes with high
expression specifically in the brain. Through the specific binding of m6A RNA-interacting proteins, this dynamic
mark plays an important role in the post-transcriptional regulation of gene expression at many steps of RNA
metabolism, including splicing, export, degradation and translation. Importantly, perturbation in the neural m6A
landscape and aberrant expression of m6A RNA biology-associated factors is linked with aging,
neurodevelopmental and neurological impairments.
Recently, it has been shown that RNA within an RNA-DNA hybrid, or so-called R-loop, can be m6A modified and
that this epi-transcriptomic modification regulates the stability of R-loops. R-loops are three-stranded nucleic acid
structures consisting of an RNA-DNA hybrid and a misplaced ssDNA that form during transcription. Although
originally thought to be quite rare, R-loops can form abundantly as part of the normal transcription process. While
transient R-loop formation is required as a part of normal gene expression, persistent R-loops can block the
elongating RNA polymerase, potentially leading to polymerase stalling, which both reduces gene expression and
promotes DNA damage. Notably, dysregulation of R-loop homeostasis has been linked with aging and human
pathologies including neurodegeneration. This proposal focuses on a novel possibility that increased persistent
R-loop formation, as a consequence of dysregulation of m6A RNA modification homeostasis, predisposes aging
brain to imbalance in gene expression leading to loss of function and ultimately, neurodegeneration.

Public health relevance
N6-methyladenosine (m6A) is a dynamic and reversible RNA modification that affects multiple aspects of RNA metabolism and recently, has been shown to regulate R-loop biology. Importantly, loss of R-loop homeostasis has been linked to aging and neurodegenerative disease. This proposal aims to gain better understanding of m6A RNA biology in the aging brain and determine how this, so-called epi-transcriptomic pathway, impacts development and progression of age-related neurodegeneration, such as Alzheimer’s disease.